Testing an Adaptive Implementation Strategy to Optimize Delivery of Obesity Prevention Practices in Early Care and Education Settings

PROJECT SUMMARY
Consuming a healthy diet and maintaining a healthy weight provide significant protection against cancer
and cancer-related mortality. Early interventions are needed to decrease the risk of developing cancer later in
life. Early care and education (ECE) is a promising setting for cancer prevention.
“Together, We Inspire Smart Eating” (WISE) is an intervention that improves children's diets in ECE. WISE
includes 4 key evidence-based practices (EBPs): (1) hands-on exposures to fruits and vegetables, (2) role
modeling by educators, (3) positive feeding practices, and (4) a mascot associated with fruits and vegetables.
Standard implementation approaches to WISE result in suboptimal implementation of WISE EBPs. Additional
implementation strategies are needed to increase adoption and fidelity to EBPs.
To date, most studies have employed an “all-or-nothing” approach, comparing multifaceted strategies to
control groups without implementation support. Thus, there is an urgent need for optimized strategies that tailor
implementation support intensity to the unique challenges and limited resources of the ECE context. The
overall objectives of this application are to determine the effectiveness and cost-effectiveness of an adaptive
implementation approach to improve adoption of the EBPs of WISE while also examining implementation
mechanisms. Our central hypothesis is that the addition of high-intensity strategies at sites that do not respond
to low-intensity strategies will improve implementation and health outcomes.
Specific Aim 1. Determine the effectiveness of an adaptive implementation strategy that tailors the
intensity of implementation support versus a low-intensity strategy. Using an enhanced non-responder
trial, we will compare the effect of continuing low-intensity strategies vs. augmenting with high-intensity
strategies. We hypothesize that sites receiving high-intensity strategies will outperform sites continuing the low-
intensity strategies on the primary outcome of intervention fidelity and on secondary child health outcomes.
Specific Aim 2. Examine moderators and mediators of implementation outcomes in a mixed-
methods design. We will test organizational readiness and teacher experience as moderators of response to
the implementation strategies. We will test educators' perceptions of barriers, local implementation climate,
and implementation leadership as mediators of the effect of the strategies on implementation outcomes.
Qualitative data will explore other potential moderators and mediators not measured quantitatively.
Specific Aim 3. Assess the incremental cost-effectiveness of the adaptive implementation strategy.
In this aim, we will estimate the cost per unit of fidelity associated with the adaptive implementation strategy.
Results will also determine the incremental cost-effectiveness of applying the adaptive strategy compared to
continuing low-intensity strategies for improving BMI and other child health outcomes.

Public health relevance
PROJECT NARRATIVE Arkansas (AR) and Louisiana (LA), the target locations for the current study, are among the states with the highest cancer and obesity rates in the US. Effective prevention and intervention programs are needed to reduce the number of children who develop unhealthy dietary habits and become adults with obesity, two key risk factors for the development of cancer. This proposal will test an adaptive implementation strategy to optimize the adoption of evidence- based practices for nutrition promotion and obesity prevention in early care and education settings.